Developing a framework to individualize surgical decision-making for older adults with primary hyperparathyroidism

PROJECT SUMMARY/ABSTRACT
This K76 Career Development award will address the large unmet need for patient-specific decision support
tools for surgical interventions in older adults and provide a platform for the applicant to become a leader in
geriatric surgery. Primary hyperparathyroidism (PHPT) is a common endocrine disorder in older adults that is
associated with serious long-term morbidity, including osteoporotic fractures, kidney stones, and chronic
kidney disease (CKD). Parathyroidectomy can prevent these morbid sequelae. However, increased surgical
risk associated with advanced age and frailty, in addition to the competing risk of death prior to achieving
benefit from surgical intervention, raises the question of whether the short-term risks of parathyroidectomy
outweigh long-term risk reduction in this group. Identifying older adults likely to benefit from surgical
interventions, such as parathyroidectomy, while preventing overuse of surgery in this vulnerable group, is
critical to improve patient-centered care. Currently, there is no standardized methodology for developing
surgical decision support for older adults that incorporates individualized risk prediction and stakeholder input
to facilitate informed, patient-centered decision-making. Therefore, this coordinated research and training
proposal aims to: 1) compare the effects of parathyroidectomy vs. medical management on the incidence of
fractures, symptomatic kidney stones, and CKD in older adults with PHPT; 2) develop and validate predictive
models for the perioperative risks of parathyroidectomy and long-term risks of fractures, kidney stones, and
CKD specific to older adults with PHPT; and 3) design and test with stakeholder feedback a PHPT decision
support tool that describes the tradeoffs of parathyroidectomy vs. non-operative management. To accomplish
these aims, Dr. Seib will obtain training in comparative effectiveness and predictive modeling, qualitative and
mixed methods research to develop decision support, and implementation science. Upon completion of this
research, Dr. Seib will have a user-tested risk/benefit calculator that will form the basis of a decision support
tool to improve individualized, patient-centered treatment recommendations for older adults with PHPT. In
addition, this research will establish a framework for developing patient-centered decision support that can be
applied to other conditions to promote appropriate surgical management of older adults. This proposal is
significant because it directly addresses the gap in decision support tools for PHPT and other surgically
managed conditions in older adults. This project is innovative because it proposes a paradigm shift to
incorporate geriatric principles to individualize treatment decisions in older adults with PHPT to optimize clinical
outcomes. At the end of the proposed research, Dr. Seib will have the data and skills necessary to successfully
pursue R01 funding for a hybrid type 1 effectiveness-implementation trial to test this decision support tool and
apply this methodology to other conditions with surgical treatment options that affect older adults.

Public health relevance
PROJECT NARRATIVE To make informed surgical treatment decisions, older adults and the providers who care for them must weigh the long-term benefits of surgery against the short-term health risks for an individual patient. However, counseling on the tradeoffs of surgical intervention too often rely on population average risk rather than individualized estimates of risks/benefits. This research will create decision support for the management of primary hyperparathyroidism in older adults and, in doing so, establish a framework for how to combine individualized risk prediction with stakeholder feedback to develop surgical decision support that will inform treatment recommendations for older adults and reduce long-term morbidity.